Bioinformatics Resources Core (BiRC)

Project Summary
With the renewal of the Puerto Rico IDeA Networks of Biomedical Research Excellence (PR-INBRE), the
Bioinformatics Resources Core (BiRC) will reinforce the original goal to strengthen the biomedical research
capacity in Puerto Rico by serving as a platform to offer hands-on support for conducting multidisciplinary
research with bioinformatics. BiRC will directly contribute to strengthening the scientific environment by
supporting competitive research projects with bioinformatics components, through technical core services, and
education and training support from a multidisciplinary team of experts. Improved oversight and mentoring in
the implementation of bioinformatics approaches in research projects, as well as close training and educational
activities for faculty, students and postdoctoral associates will be a hallmark of this renewed BiRC program. A
multidisciplinary team of experts will be working together to provide support to research projects in the
implementation of bioinformatics approaches and data analyses including areas of metagenomics,
metatranscriptomics, mathematical modeling, research design, and power analyses, thus providing the
expertise to efficiently and cost effectively conduct next generation research in a collaborative environment.
The primary objective is to train faculty, students and postdoctoral associates who can apply bioinformatics
skills in their research projects, develop new collaborative partnerships between PUI and lead investigators
with BiRC researchers, and improve science education by integrating computational experiences in traditional
biology courses through new Statistics, and the Research and Education (R&E) Sub-cores. We expect to
sustain a vigorous biomedical training pipeline in bioinformatics that contributes to increase bioinformatics and
computational skills in the scientific workforce and at PR-INBRE network universities.
postdoctoral